Summer Undergraduate Program in Emory Renal Research (SUPERR)

PROJECT SUMMARY
The Summer Undergraduate Program in Emory Renal Research (SUPERR) will promote an appreciation for
the study of kidney, urology, and hematologic (KUH) diseases among undergraduate students who are
interested in furthering their scientific research and could be encouraged to pursue a career in biomedical
scientific research. Early exposure of undergraduate researchers to these exciting areas of study will give
promising students first-hand experience in laboratory methods to answer questions that directly affect human
health and disease. Our goal is to foster sustained interest in KUH diseases, thereby increasing the number of
students applying to PhD, MD/PhD, and MD programs, and increasing the cadre of scientists in the biomedical
workforce studying these topics in the future. SUPERR will expose undergraduate students to current
questions in KUH diseases that are being investigated by NIDDK supported investigators at Emory University.
Following a national recruitment, selected students will participate in an 11-week didactic and laboratory-based
experiential program on our Atlanta campus to advance their knowledge of nephrology, urology, and
hematology research through laboratory experimentation, clinical research, career development activities,
responsible conduct in research training, and opportunities to present and share their research. Specific
targeted skills will include data acquisition, analysis and interpretation, and scientific presentation. The
culmination of the summer training will be participation at the NIDDK sponsored Summer Student Research
Symposium. Our overall objective is to train the next generation of scientists and physician-scientists in
nephrology, urology, or hematology research. Specific Aim 1 is to continue our undergraduate program that
garners interest in kidney, urology, or hematology diseases. Specific Aim 2 is to promote interest in kidney,
urology, and hematology disease research among women and underrepresented minorities. Specific Aim 3 is
to increase undergraduate enrollment into PhD, MD/PhD, and MD programs that excel in nephrology, urology,
or hematology research.

Public health relevance
PROJECT NARRATIVE The Summer Undergraduate Program in Emory Renal Research (SUPERR) will provide a research and didactic experience in the study of kidney, urology, and hematologic diseases. Following a national recruitment, the selected students will participate in an 11-week didactic and laboratory or clinical research based experiential program at Emory, culminating with participation in the NIDDK sponsored Summer Student Research Symposium.